Dissecting the impact of genomic variants on hallmarks of T cell anti-tumor activity

PROJECT SUMMARY/ABSTRACT
While a fraction of patients with melanomas and leukemias experience durable response to T cell-
based therapies, including adoptive transfer of tumor infiltrating lymphocytes (TILs) and chimeric
antigen receptor T (CAR-T) cells, respectively, a majority do not. Emerging studies have found
that sporadically occurring or purposefully engineered single-nucleotide variants (SNVs) in T cell
signaling genes have the potential to powerfully modulate cellular therapies. To this end, our group
established novel methods for highly efficient screening of single-nucleotide variants in primary
human T cells using CRISPR base editing. Using these methods, we identified a series of SNVs
in genes encoding PI-3-kinase subunits (PIK3CD and PIK3R1), which enhance multiple hallmarks
of T cell activity, as well as several SNVs that promote long-term in vivo persistence in humanized
mice, including in PPP3CA (encoding the calmodulin-binding catalytic subunit of calcineurin). In
multiple T cell immunotherapy models, including tumor-specific TCR-engineered T cells against
melanoma and CAR-T cells against leukemia, engineering T cells with PIK3CD SNVs enhanced
antigen-dependent PI3K pathway signaling, proinflammatory cytokine production, and in vitro
tumor cell killing. Moreover, these SNVs enhanced tumor cell killing in melanoma models of CD58
loss, a mechanism of immunotherapy resistance shared across several cancer types. This
proposal seeks to perform in-depth mechanistic and in vivo functional studies of these SNVs in a
panel of immunotherapy models. In Aim 1, we propose to define the mechanisms by which
PIK3CD SNVs modulate T cell activity and evaluate the in vivo impact of these SNVs in several
murine xenograft immunotherapy models, including NY-ESO-1 specific T cells targeting
melanoma and CD19-CAR T cells targeting leukemia. In Aim 2, we propose to use these models
to perform mechanistic and in vivo efficacy studies of PIK3CD SNVs in the setting of tumor CD58
loss, a shared mechanism of therapy resistance in melanoma and leukemia. In Aim 3, we will
perform rational combinatorial base editing studies in these in vivo models, coupling variants in
PIK3CD which promote anti-tumor activity with variants in PPP3CA which enhance in vivo
persistence, with the goal of further enhancing the durability of tumor clearance. These aims offer
a powerful breadth and depth of study of promising SNVs which may enhance immunotherapies,
spanning from mechanistic T cell biology to translational xenograft models. With the guidance
from exceptional mentors and collaborators and access to the unparalleled scientific research
environment at Columbia University’s Irving Medical Center, this project will prepare me for a
successful career as a physician-scientist in the field of cellular immunotherapy.

Public health relevance
PROJECT NARRATIVE While a fraction of patients with melanoma and leukemias experience durable response to T cell- based therapies, including adoptive transfer of tumor infiltrating lymphocytes (TILs) and chimeric antigen receptor T (CAR-T) cells, respectively, a majority do not. To address this, our group has established novel methods for pooled screening of single-nucleotide variants (SNVs) in primary human T cells using CRISPR base editing, and leveraged these methods to discover a series of SNVs in genes encoding PI-3-kinase subunits (PIK3CD and PIK3R1) which enhance the in vitro anti-tumor activity of multiple T-cell immunotherapies, as well as several SNVs that promote in vivo T cell persistence in humanized mice. This proposal seeks to characterize the mechanism by which these SNVs modulate T cell activity, evaluate the in vivo functional impact of these SNVs in a panel of clinically relevant murine xenograft immunotherapy models, including models of therapeutic resistance (CD58 loss), and rationally engineer combinatorial SNVs in T cell immunotherapies to further enhance the durability of in vivo tumor clearance.